Design for Implementation: The Future of Trauma Research and Clinical Guidance

Program Director/Principal Investigator: LaGrone, Lacey N.
Project Summary/Abstract
Injury accounts for 47% of deaths in Americans ages 1-46, and is associated with an annual $672 billion cost
in healthcare expenses and lost productivity. Injury outstrips cancer, diabetes, and heart disease in prevalence
and cost (1-2). There remains vast inequity in access to quality injury care, with an estimated one-in-five
trauma deaths being preventable. The current state of affairs for trauma knowledge transfer leaves many
trauma providers with inadequate access to up-to-date, resource-relevant, user-friendly, trustworthy clinical
guidance. The public domain contains redundancy and gaps in the existing clinical practice guidance, which is
developed primarily by and often primarily for, academic level I trauma centers, without representation of
geography, discipline, or cultural diversity in origin or applicability. The 2016 National Academies of Science,
Engineering and Medicine report on a national trauma care system acknowledged that a “lack of formal,
funded mechanisms for coordination, communication, and translation in trauma care has…contributed…to
suboptimal outcomes for injured patients in the United States (5).”
The three-year conference series, Design for Implementation: The Future of Trauma Research and Guidance
will apply best practices from dissemination and implementation science, Agile team facilitation, and adult
learning theories to inclusively engage stakeholders in order to better understand user needs, and to ultimately
develop a national strategy for clinical guidance development and dissemination. The conference will leverage
the expertise, perspective, and position of leaders and end-users with global expertise in dissemination and
implementation science, hospital administration, development, clinical care, informatics and patient experience.
The conference series will follow implementation science principles in structure, with each year having an
education, data acquisition, and execution focus. The first year will focus on context inquiry and stakeholder
engagement, second on perceptual implementation outcomes (acceptability, appropriateness, feasibility), and
the final year on behavioral implementation outcomes (adoption, fidelity, sustainability). The conference series
is intended to inform development of a national plan, for which additional funding, such as a Dissemination
Practice grant, will be sought.
Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator: LaGrone, Lacey N. Project Narrative The Design for Implementation: The Future of Trauma Research and Clinical Guidance conference series will facilitate alignment of stakeholders in the definition, and early execution, of next steps toward an ideal future state for the evidence-based care of the injured patient. The burden of injury is high, and the current variability in outcomes unacceptable: 47% of deaths among Americans ages 1-46 are due to injury, and a patient is twice as likely to die at the worst performing U.S. trauma center as compared to the best. This dissemination and implementation science initiative, in collaboration with the Coalition for National Trauma Research (CNTR), will increase the rapidity, equity, and effectiveness with which healthcare interventions and guidance inform excellence without exception in the care of the injured patient. Page Continuation Format Page